Leveraging Heterogeneity in Autosomal Dominant AD to Elucidate Pathophysiology and Improve AD Biomarkers

Project Abstract:
Alzheimer’s disease (AD) and related dementias (ADRD) represent an enormous burden for patients,
families, and health care systems, underscoring the urgent need for efficacious, widely-accessible, and cost-
effective disease-modifying therapies. The over-production of longer, aggregation-prone Ab fragments (esp.
Ab42 and 43) relative to shorter, non-aggregating fragments (esp. Ab37 and 38) appears to be a critical
initiating pathological event in both late-onset, sporadic AD (LOAD) and Autosomal Dominant AD (ADAD).
The balance between production of aggregating and non-aggregating forms of Ab is a direct result of the
efficiency and kinetics with which the γ-secretase complex sequentially cleaves b-amyloid precursor protein
(APP). Subtle alterations in γ-secretase function can have profound neurodegenerative and cognitive
consequences, while modulation of γ-secretase has therapeutic potential in both LOAD and ADAD. Over 200
pathogenic variants in Presenilin-1 (PS1), the key catalytic subunit in the γ-secretase complex, have been
identified and are the most common cause of ADAD. Despite near complete penetrance, there is substantial
heterogeneity in age of symptom onset (a range of >30 years) and rates of cognitive and biomarker change
between PS1 variants. In this proposal, we hypothesize that differences in γ-secretase function between
ADAD-causing PS1 mutations measured in cell-based, biochemical, and primary neuronal model systems will
help explain heterogeneity in age of symptom onset, cognitive, and biomarker changes seen in PS1
pathogenic variant carriers in vivo. We test this hypothesis through systematic characterization of γ-secretase
function across PS1 pathogenic variants and comparing the resulting immunoassay and mass spectroscopy
measures of g-secretase function to cognitive and biomarker data from carriers of corresponding PS1 variants
participating in the Dominantly Inherited Alzheimer’s Network Observational Study (DIAN-Obs), a large
international study in which over 80 unique PS1 pathogenic variants are represented. Determining which
variant-specific differences in γ-secretase function translate into differences in age of symptom onset and
cognitive and biomarker trajectories in PS1 carriers represents a unique opportunity to elucidate AD
pathobiology, inform therapeutic and biomarker development, and impact ADAD clinical trials.

Public health relevance
Project Narrative: Alzheimer’s disease (AD) and related dementia syndromes (ADRD) represent an enormous challenge for patients, families, caregivers, and health care systems. Rare cases of autosomal dominant AD (ADAD) offer a unique window into the biologic changes that cause AD and a compelling opportunity to intervene to stop the development of early-onset AD. In this project, we will characterize how the hundreds of different, disease- causing genetic variants in Presenilin-1 (the most common cause of autosomal dominant AD) are similar and different in their biologic effects, and thereby better understand AD biology, inform drug development, and improve chances for success in ADAD clinical trials.